DESMOPRESSIN IN NORMAL VOLUNTEERS--RELATIONSHIP OF ETS CURRENT DENSITY

To test the delivery of Desmopressin by Electrotransport Therapeutic Systems in normal volunteers using a skin patch and evaluating its pharmacokinetic and pharmacodynamic properties.